Isolating the role of endogenous mu-opioid activity in the VTA during natural reward

SUMMARY: Opioid use disorder and opioid overdose death rates in the United States reached unprecedented
levels during the COVID-19 pandemic. Understanding how endogenous opioid activity affects natural reward
seeking is crucial to understanding the neuropharmacological basis of opioid use disorder. Previous research
implicates the mesolimbic dopamine pathway, which refers to dopamine neurons projecting from the Ventral
Tegmental Area (VTA) to the Nucleus Accumbens (NAc), in reward and addiction. Recent studies show that
gamma-aminobutyric acid (GABA) containing neurons in the VTA (VTAGABA) provide local inhibition of dopamine
neurons that synapse onto the NAc, thus playing a role in regulating reward behaviors. Importantly, these
VTAGABA neurons contain a variety of G-protein coupled receptors, specifically the µ-opioid receptor (MOR).
However, the exact role of these receptors and their signaling play in VTAGABA neurons and consequent
regulation of natural reward is unknown. The source of endogenous opioid neuropeptide onto these MORs, and
how these impacts signaling and activity has not been described. The central hypothesis of this proposal is that
µ-opioid receptor signaling on VTAGABA neurons is regulated by afferent endogenous opioid peptides, resulting
in disinhibition of VTAGABA neuron excitability. This results in control of dopamine neuron activity, and ultimately
the expression of natural reward-seeking. This proposal directly addresses NIDA's Priority Scientific Area 1 that
aims to further understand the molecular, neuropharmacological and circuit changes induced by drug use. Aim
1 will isolate the role of endogenous µ-opioid peptides in the VTA on dopamine signaling and natural reward-
seeking. Aim1A uses ex vivo two-photon imaging and neuropharmacology approaches to visualize VTAGABA and
VTA DA dynamics. Aim1B will investigate the effects of MOR ablation in the VTA on dopamine activity and
behavior. Aim 2 will isolate the source and dynamics of endogenous µ-opioids in the VTA during natural reward
behavior. In Aim 2A, I will use viral tracing techniques to anatomically visualize inputs from the lateral
hypothalamus (LH) to the VTA. Aim 2B will test the effects of endogenous µ-opioid signaling on VTAGABA and
DA activity in the NAc during reward seeking behaviors. In Aim 2C, I will use molecular approaches including
CRISPR gene-editing and a recently developed µ-opioid biosensor (µMASS1) to understand the spatiotemporal
aspects of MOR signaling in VTAGABA neurons during reward seeking. This career development training and
series of experiments will provide insight into the role of endogenous MOR signaling on dopaminergic activity
and natural reward-seeking. For this proposal, I will train in slice electrophysiology, two-photon slice imaging,
gene-editing, molecular neuropharmacology, and behavioral approaches to understand how specific
neuropeptides regulate reward circuits. This F31 proposal will greatly advance my career development plan and
prepare me for a career as an independent, academic neuropharmacologist.

Public health relevance
Project Narrative Opioid use disorder and opioid overdose impacted many tens of thousands in the United States alone. However, the fundamental basic mechanisms by which opioids act in the brain to influence natural reward behaviors remain unknown. This proposal will isolate how endogenous opioid systems function in reward circuits within the context of natural reward seeking, providing new insight into how opioid systems natural states may be negatively impact in substance use disorders.